Elucidation of the role of Plasmodium falciparum folate transporters in antifolates transport and implication on drug design

PROJECT SUMMARY
Antifolates (drugs that target enzymes the folic acid biosynthesis pathway) are widely used to treat a
number of infectious disease, including malaria. Although drug resistance is spreading, antifolate drug
combination Sulfadoxine-Pyrimethamine (SP) remains the safest and most efficient treatment option
for preventive treatment of malaria in pregnant women and in infants. Developing alternative treatment
options is therefore crucial.
SP resistance is mainly caused by mutations in the folate enzymes. This has been addressed with the
development of P218 clinical candidate, which is equally efficient on SP-sensitive and SP-resistant
parasite. Yet, growing evidence from our group and others shows that folate transporters may play an
important role in antifolate sensitivity and resistance. Understanding (anti)folate transport therefore
appears crucial for the development of novel potent drug candidates.
Plasmodium falciparum possesses only two folate transporters, PfFT1 and PfFT2, which function have
not been yet characterized. This project proposes to investigate PfFT1 and PfFT2 function using a
series of biochemical assays. Their natural substrate scope will be identified, and their ability to
transport a series of antifolate drugs will be assessed. The determinants of (anti)folate-transporter
recognition will be investigated and used to construct a structure-relationship activity model. The
knowledge generated from this project will be valuable to guide the development of new antifolate drug
candidates with improved transport properties.

Public health relevance
PROJECT NARRATIVE Despite the spread of drug resistance, antifolates remain a key player for the protection of vulnerable populations against malaria, and novel antifolate drug candidates are urgently needed. Growing evidence suggests an important role of the folate transporters PfFT1 and PfFT2 in antifolates activity and resistance, but little is known on their mode of action. We propose to characterize PfFT1 and PfFT2 and to build a structure-activity relationship model of antifolates intake, which will guide future antifolate drug design.